COMPUTATIONAL IMAGING CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. COMPUTATIONAL IMAGING CORE This Core facility provides light microscopy, whole slide scanning, stereology, digital imaging, image database development, and consultation services, primarily for the CNPRC, but also for all campus departments on a recharge basis. The goal is to assist faculty, staff, and students with their research needs for qualitative and quantitative imaging applications. This Core assists with the production of publication quality images and offers consultation on experimental approaches for use with its equipment. Additionally, it is engaged in digitizing and correcting archived film images from various sources but primarily those created by the Pathology Service at the CNPRC. The Core also provides a service to annotate and upload fully corrected digital images into the CNPRC image database. Uploaded images are linked in the database to other information for a specific animal and made available to all who have been granted access. Instrumentation housed in the Core is available 24 hours a day, 7 days a week for trained CNPRC users. Consultation, training, and support service, along with access to the equipment for other departments, is available from 8-5 Monday through Friday. The facility houses the following equipment: + A Cryostat for frozen sections. + Microtomes for paraffin and plastic sectioning. + Sample preparation equipment for plastic processing and embedding. + Data storage servers (expandable multi-terabyte volumes) for archiving client, Pathology Unit, and Imaging Core data. These systems provide rapid access to very large (multi-gigabyte) files or data sets that would otherwise require hours to transfer from other locations in the CNPRC. + Web-based calendar for instrument reservations. + An Olympus BX61 research microscope with 1 color and 2 B/W cameras, Olympus DSU spinning disk confocal system, computer controlled stage and focusing system, Molecular Devices MetaMorph image capture and analysis software, and Intelligent Imaging Innovations SlideBook software for stereology and image data collection. + A second Olympus BX61 microscope with Intelligent Imaging Innovations SlideBook software for stereology technique development by the Core's staff. + A graphics workstation, flatbed scanner, and a high-quality color corrected printer;these are used for publication quality prints, converting film to digital images, image correction, and image archiving. + Document scanners for rapid digitization and OCR conversion of paper records. + A Delta Vision Microscopy System and computer workstation for very high resolution multi-dimensional fluorescence imaging with deconvolution. + A computer workstation for offline analysis of stereology data and large multidimensional image analysis. + A recently updated Visiopharm VIS/CAST Grid Stereology System for quantitative data collection and automated image analysis. + Adobe Photoshop, Adobe Illustrator, and Adobe LightRoom software to support all digital imaging efforts of the Core [unreadable]all computers are outfitted with spectrophotometrically color balanced monitors. + A fluorescence stereomicroscope outfitted with a high sensitivity color camera coupled to a computer system. + A dual-head brightfield stereomicroscope + An Olympus VS110 virtual microscopy / whole slide scanning system for brightfield, DIC and fluorescence imaging + Cell Biosciences FluorChem-E scanner for gels and blots